EFFECT OF INFLUENZA VACCINE ON RATES OF PNEUMOCOCCAL BACTEREMIA

Use of CDMAS to analyze date to determine the effectiveness of influenza vaccine in persons 65 and older in preventing pneumococcal bacteremia; obtain baseline rates of pneumococcal bacteremia, calculation of case-fatality rates; and calculation of Medicare dollar savings.